NOA correction: North Carolina Occupational Health Surveillance Program

Project Abstract for Expanded Program in Chemical Exposure Surveillance
In 2018, 2.1 million poisoning exposures were reported to US Poison Control Centers; 31,316
reports listed the reason for the call as occupational. Workplace injuries and illness caused by
chemical exposures are preventable. Successful interventions to improve workplaces safety
begin with having the data necessary to understand the magnitude of the problem.
North Carolina uses a multipronged surveillance approach to respond to chemical releases and
exposures, with an emphasis on monitoring and preventing occupational injuries. Three
surveillance systems work together to monitor emergency chemical releases and exposures to
two ubiquitous and harmful substances – carbon monoxide and pesticides. This data is
leveraged to inform timely public health response and intervention for specific incidents.
North Carolina is seeking expanded funding in surveillance of chemical exposures to:
1. Integrate chemical exposure surveillance, include acute pesticide poisonings chemical
releases, and occupational carbon monoxide poisonings into a unified software platform
for more effective response.
2. Increase capacity to conduct follow-back interviews and referrals for chemical
exposures, including occupational carbon monoxide poisonings, pesticide poisonings.
3. Provide emergency response support and multidisciplinary occupational health
consultations to protect public health and employees.
4. Maintain, develop and promote collaborative projects focused on emerging occupational
health surveillance priorities with a committed network of in-state partners.
5. Work with out-of-state regional and national partners to design and promote best
practices for occupational surveillance.
Public health surveillance at the state levels has been greatly impacted by the COVID-19
pandemic. Our staff have been deployed to the response since January 2020, which has
delayed several of our routine surveillance activities. However, the recognition that occupation
impacts health has received more national attention and public awareness during the COVID-19
pandemic. Although the lack of industry, occupation, race, and ethnicity information in many
data sources has limited our ability as public health professionals to adequately respond to the
pandemic, we can build on the national recognition to innovate how we monitor and improve
occupational health in this county.

Public health relevance
Project Narrative for Expanded Program in Chemical Exposure Surveillance The NC Occupational Health Surveillance Program - Expanded Program project for Chemical Exposure Surveillance is focused on integrating and reporting findings from case-based occupational surveillance data sources, and increasing the capacity for follow-back investigations for ensuring complete and quality data. Reported findings will be used to increase referrals to regulatory agencies for incidents of acute carbon monoxide or pesticide exposures and provide emergency response support and occupational health consultations to protect the health of workers. Activities will be achieved through maintaining, developing and promoting collaborative projects with in-state and out-of-state partners focused on emerging occupational health surveillance priorities and promoting best practices for occupational surveillance.